Elyra 7 Lattice SIM2 Super-Resolution Microscope

7. Project Summary/Abstract
Fluorescence microscopy is one of the most powerful and versatile techniques available for biological studies.
These days, fluorophore-labeled molecules and genetically encoded fluorescent proteins are often bright and
readily distinguishable from background signals, making it easy to obtain high contrast images and measure
protein expression, localization, and activity in living cells. However, in light microscopy, resolution is
fundamentally limited by the properties of light diffraction, which prevents the resolution of structures smaller
than approximately half the wavelength of light. Electron microscopy has a much higher resolution than light
microscopy and has long been relied on to visualize cellular structures smaller and/or closer together than 250
nm. However, fixation, dehydration, and ultrathin sectioning are required during sample preparation for electron
microscopy, making it technically challenging, prone to artefacts, and incompatible with live imaging.
Therefore, microscopic techniques that combine the nondestructive nature of light microscopy and the
nanometer resolution of electron microscopy (i.e., super-resolution techniques) have been the focus of much
research and development in recent years. We propose to purchase an Elyra 7 Lattice SIM2 system, which
achieves substantial improvements in spatial and temporal resolution and efficiency while decreasing the light
dosage to the sample in two ways. The first way involves the use of lattice structured illumination microscopy
(SIM). In lattice SIM, the sample area is illuminated with a lattice spot pattern, which leads to a dramatic
increase in imaging speed, higher contrast, more robust image reconstruction, and less laser dosage for
sample illumination than conventional SIM. The second way involves the use of a novel image reconstruction
algorithm, termed dual iterative SIM or SIM2. At Loyola University Chicago, the NIH sponsored research of
many scientist requires fluorescent microscopy to characterize the interaction between small structures (e.g.
virus, proteins, RNA) and organelles that mediate key biological functions. To understand these interactions, is
critical that our scientists have the ability to resolve them with the finest possible detail and to characterize how
cellular and molecular events unfold in real time in a live context. The Elyra 7 Lattice SIM2 system will be
housed in our Core Imaging Facility, giving widespread access to this revolutionary imaging technology.
Compared to similar instruments in the Chicago area, this instrument boasts unmatched versatility, allows for
superior temporal and spatial resolution, is more efficient, and has a larger field of view. Therefore, this system
will greatly enhance the NIH sponsored research of the Loyola University Chicago user group.

Public health relevance
8. Project Narrative Access to a wide field super-resolution microscope will increase the capabilities and facilitate the cell biology research of the user group at Loyola University Chicago and others in the Chicago area. This, in turn, will facilitate a greater level of productivity and significantly advance the knowledge gained from NIH sponsored research at Loyola University Chicago and the greater Chicago area.